Investigating and targeting oxidative stress and ferroptosis in frontotemporal dementia

Frontotemporal dementia caused by mutations in microtubule-associated protein tau (MAPT), including the
N279K mutation, is a common cause of early-onset dementia. It is neuropathologically characterized by toxic
aggregation of hyperphosphorylated tau, glial activation, and neurodegeneration. The factors contributing to
the disease are likely numerous and poorly understood, and no disease-modifying therapies exist for FTD.
Oxidative stress (OS) occurs when a cell’s innate antioxidant system is overwhelmed by reactive oxygen
species, and oxidative modifications of biological molecules have important consequences on protein, DNA,
and lipid function. In particular, uncontrolled lipid peroxidation can lead to ferroptosis, a specific cell death
pathway which we found to be enriched in FTD postmortem brain and may contribute to neurodegeneration.
We also identified an OS and neuroinflammatory phenotype in postmortem brain from FTD patients and
induced pluripotent stem cell (iPSC)-derived neurons from FTD patients. Specifically, FTD iPSC-derived
neurons show upregulation of the gene secreted phoshoprotein-1 (SPP1) and its protein product osteopontin
(OPN), which can activate iPSC-derived microglia in vitro. Given the centrality of OS in our FTD models and
the apparent association with SPP1, this proposal seeks to investigate mechanisms of OS generation and
downstream sequelae in FTD. In aim 1, I will interrogate the effects of different classes of oxidative and
ferroptotic stressors on FTD MAPT N279K iPSC-derived neurons. In aim 1a I will assess cell viability and lipid
peroxidation. In aim 1b I will assess tau pathology and neurite outgrowth. In aim 1c I will attempt to rescue any
effects seen in aims 1a and 1b by co-treating with antioxidant and ferroptosis inhibiting compounds. In aim 2 I
will characterize astrocyte-neuron crosstalk in the FTD context. First, in aim 2a I will generate iPSC-derived
astrocytes from FTD MAPT N279K patients or healthy control patients and treat with OPN and assess for
astrocyte reactivity. In aim 2b I will generate antioxidant response gene reporter astrocytes and treat with Ctrl
or FTD neuron conditioned medium to determine the role of neuron-secreted factors in astrocyte response.
Finally, in aim 3 I will explore the potential of targeting OS in FTD. I will xenotransplant FTD or Ctrl neural
progenitor cells into mice forebrains and treat systemically with liproxstatin, an antioxidant and ferroptosis
inhibiting compound. In aim 3a I will characterize proteins involved in these pathways as well as glial reactivity
and graft survival by histology. In aim 3b I will perform snRNA-seq on micro dissected grafts to map changes in
gene expression profiles in response to OS targeting.

Public health relevance
Neurodegenerative diseases including frontotemporal dementia are increasing in prevalence and lack effective treatments. Oxidative stress has been implicated in neurodegenerative diseases and can contribute to development of ferroptosis, a non- apoptotic iron-dependent form of cell death. This proposal seeks to investigate the role of oxidative stress and ferroptosis in frontotemporal dementia across different central nervous system cell types.